REDUCING PESTICIDE EXPOSURE IN MINORITY FAMILIES

DESCRIPTION (Taken from Applicant's Abstract) This is a competing continuation of a community-based participatory research program focusing on pesticide contamination in migrant farm worker communities. Oregon Health Sciences University Center for Research on Occupational and Environmental Toxicology and the Oregon Child Development Coalition propose to extend the participatory research model that has been developed to increase community capacity and to build knowledge on the nature and extent of childhood exposures to pesticide and resulting health effects. The project includes involvement from representatives of academic institutions, child and family educational, health, and social services, and the agricultural community. The investigators propose to extend their program of research beyond the state of Oregon to accomplish the following specific aims: 1) Develop and validate a pathway model of organophosphate pesticide exposure for children residing near tree fruit orchards. 2) Conduct a longitudinal investigation of pesticide residue analysis, work practices, home characteristics and biological markers of exposure in migrant families residing in multiple homes and communities throughout a year. 3) Evaluate specific neurobehavioral outcomes in Latino children who speak Spanish and indigenous languages, living in homes with measured pesticide residues and in children living in homes with minimal measurable pesticide residues. 4) Assess the effectiveness of accepted methods of intervention including health education and environmental exposure reduction on changing behavior and reducing pesticide exposure in the migrant agricultural community. The project also includes mechanisms to strengthen and expand the partnerships among migrant farm worker communities to increase the capacity of the community to address issues of environmental exposures and health. Training opportunities are provided for youth from the Latino farm worker community in environmental issues in affected communities. In addition to measuring the outcome of our research interventions in modifying exposures to pesticides and resulting health effects they have incorporated a comprehensive evaluation plan including measures to document increased research capacity in the community, leveraging by obtaining additional funding for further efforts, sustainability, culturally appropriate tools, policy or systems change, and impact on the field.